Targeted Temperature Modulation with Smart Radiometric Monitoring for Effective and Long-Lasting Opioid-Free Pelvic Pain Relief - A Novel Low-Cost, Portable, Tampon-sized Thermal Transfer Device.

ABSTRACT
Pelvic pain (PP) is associated with more than 20 different, clinically identified, maladies, such as Urinary Tract
Infection (UTI), Menstrual Cramps (MC), Endometriosis (EM), Overactive Bladder (OAB) and Interstitial
cystitis/Painful bladder syndrome (IC/PBS). These painful and debilitating conditions often have a dramatic
negative impact on the quality of life (QOL) of millions of PP sufferers, from decreased work productivity and
school performance, to declined sexual life and happiness. PP has been also associated with increased abuse
of opioids and psycho-pharmaceuticals, ultimately leading to death by overdose and suicides. In addition to the
burden to patients and their family, the economic direct and indirect PP cost is a significant fraction (>20%) of
the 635B$ linked to chronic pain in US. Globally, pelvic pain affects one in five women and one in twelve men.
Although treatments, including neural stimulation, are available, they are costly and lose effectiveness over time
in >30% of patients. Patients with current untreatable chronic PP require a novel treatment approach that can
relieve them from their debilitating symptoms. Significant relief of pain and reduced urination frequency has been
recently associated with thermal modulation of pelvic floor. H3Pelvic has successfully developed a Contrast
Applied Therapy (CAT) system modulating rapidly and comfortably temperature (cold/warm) via a water-
circulating perineal membrane in a soft seat. When a properly sized vaginal or rectal probe with superior thermal
conductivity is combined with the CAT system, the pain relief can be remarkable: an initial cohort of patients with
refractory IC, unresponsive to drugs or neural stimulation, with a daily 45min vaginal cooling, resumed normal
undertakings, restarted school, work and sexual activity, leading to an overall happier and productive life.
We propose to optimize a probe design to maximize targeted delivery of thermal modulation using heatpipe
technology, including real-time temperature tracking by passive microwave radiometry. RICAT (Radiometry
Integrated CAT) will use probe-integrated smart radiometry to monitor deep tissue temperature. By leveraging
machine learning, a minimal set of sensors shall accurately reconstruct temperature in the target region and
maximize pain reduction. The Specific Aims for this first Phase are: 1) Optimally integrate radiometric sensors
and smart planning/control software in a RICAT prototype; 2) Compare radiometric profiles with invasive needle
sensors and perform histology in ex-vivo tissues and 7 pigs undergoing vaginal or rectal cooling/warming cycle.
The goal of this Phase I is to integrate radiometric sensing into the thermal probe and test the probe’s ability to
deliver consistent cooling and heating in the pelvic region in pre-clinical settings using healthy pigs. The data
collected will allow us to move to Phase II, which will include a human trial in refractory IC patients. We expect
that the animal study will show that RICAT optimally delivers pain-relieving thermal modulation to the pelvic
region(s) effectively and reliably. Successful Phase I completion will pave the path towards clinical translational
of a safe and effective pain-relieving technology to millions of patients suffering from debilitating pelvic pain.

Public health relevance
PUBLIC HEALTH AND RELEVANCE STATEMENT We propose to combine multi-frequency radiometry with thermal modulation (cold/hot) of the pelvic region via a vaginal or rectal heatpipe-enhanced thermal wicking probe to reduce dramatically the pain associated with refractory interstitial cystitis and other chronic pelvic pain conditions. The novel, affordable and effective intraluminal therapeutic system will improve the quality of life, allow return to normalcy and support the personalized hospital-at-home care, ultimately benefiting millions of low-resource patients in US and worldwide.